Piloting Y-AMBIENT: A Quality of Life Intervention for Young African American Breast Cancer Survivors

Project Summary/Abstract African American (AA) women who are young (less than age 45) are more likely to develop breast cancer, report poorer quality of life (QOL), and face negative social determinants of health (e.g., low socioeconomic status, limited access to care, discrimination) than young White women. Yet, there are no published interventions that comprehensively address QOL (i.e., physical, psychological, social and spiritual well-being) in young AA survivors. Using input from young AA survivors and healthcare providers, we adapted an existing QOL intervention to target young AA survivors (Y-AMBIENT). Y-AMBIENT is a four-month, telephone-based intervention with three QOL-themed education sessions, three follow up sessions, written materials, and videos designed to improve QOL. We propose to evaluate processes and preliminary outcomes of a targeted QOL intervention vs. attention control in young AA survivors of early (I-II) & late (III) stage breast cancer. We will conduct a two-arm, repeated measures pilot study to evaluate feasibility, acceptability, and preliminary health- related outcomes of Y-AMBIENT vs. an attention control (scripted socialization). We will recruit 40 young AA survivors who have completed primary breast cancer treatment (n=20 per group and equal representation of those with a history of early and late stage breast cancer within). We will measure feasibility via study recruitment and retention (i.e., study enrollment and study contact completion) and protocol acceptability with satisfaction, usefulness, use of strategies via our Topical Concern and Strategy Sheet. We will triangulate qualitative and quantitative responses from each study contact to (a) identify perceptions of satisfaction and usefulness, (b) willingness to participate in aspects of the protocol (participant burden), and (c) use of self- management strategies to self-manage concerns. At baseline, two-, and five-months, we will examine health- related outcomes (i.e., QOL, spiritual well-being, self-efficacy, and social support) within and between groups using descriptive and multiple-effects modeling techniques. This study will provide preliminary data to support a large randomized controlled trial of the Y-AMBIENT.

Public health relevance
Project Narrative African American (AA) women who are young (less than age 45) are more likely to develop breast cancer, report poorer quality of life (QOL), and face negative social determinants of health (e.g., low socioeconomic status, limited access to care, discrimination) than young White women. This two-arm study will evaluate feasibility, acceptability, and preliminary outcomes of Y-AMBIENT (a targeted and telephone-based QOL intervention for young African American survivors of stage I-III breast cancer) vs. an attention control (scripted socialization). Findings will inform a randomized controlled trial to test intervention efficacy.